Small Molecule Inhibition of Noggin to Induce Spinal Fusion

Abstract
This application proposes to address one of the major translational limitations of using Bone Morphogenetic
Proteins (BMPs) for local bone induction in spine fusion. Since the FDA approval of recombinant human BMP-
2, it has consistently induced bone formation in widespread clinical use, but also has been associated with
several local side effects including inflammation, vascular permeability, seromas, hematomas, and nerve root
irritation. Our overall strategy is to locally inhibit the primary natural BMP antagonist, noggin, creating a BMP-
privileged zone that allows for lower BMP levels to induce bone formation. We propose to engineer a hybrid
scaffold combining a collagen sponge and a poly(lactic-co-glycolic acid) (PLGA) or a nanostructured mineral
coating to deliver a novel small molecule that blocks noggin activity. In compelling preliminary data from rabbit
spine fusion studies, we show a significant increase in noggin production in surrounding soft tissue, an auto-
induction of local BMP-2 production in the fusion site, and a subsequent increase in noggin production in the
fusion site. To blunt the noggin negative feedback loop, we computationally designed a novel Small Molecule
Inhibitor (SMI) of noggin that blocks its binding to BMP-2 and enhances activity of exogenous and endogenous
BMPs. To provide spatiotemporal control of the noggin SMI, we engineered a hybrid collagen scaffold with either
a nanostructured mineral or a PLGA coating. This innovative noggin SMI strategy will allow lower BMP levels to
locally induce bone formation through enhanced cellular responsiveness. We hypothesize that locally blocking
the activity of noggin will disrupt/uncouple the negative feedback loop and allow the positive feedback loop to
prevail, thereby resulting in greater signal amplification of BMP-2 within the delivery scaffold. We propose the
following Specific Aims: Aim 1: To determine the noggin SMI to BMP-2 ratio and dose windows to maximize the
positive and minimize the negative BMP feedback signaling loops in vitro and osteogenesis in vivo. Aim 2: To
engineer a hybrid biomaterial delivery system to control spatial and temporal release of the noggin SMI to
potentiate BMP-2 responsiveness. Aim 3: To demonstrate that a hybrid noggin SMI scaffold can lower the dose
of BMP-2 required to produce spine fusion. The potential impact of a decreased BMP dose is substantial for
improving the safety of activating the BMP signaling pathway for spinal fusion clinically.

Public health relevance
Project Narrative The clinical use of Bone Morphogenetic Proteins (BMPs) for local bone induction in spine fusion but is often complicated but unwanted side effects. In this work we propose to locally inhibit the primary natural BMP antagonist, noggin, with a novel small molecule inhibitor and hybrid scaffolds creating a BMP-privileged zone that allows for lower BMP levels to induce bone formation. Together these strategies will provide a novel technology to safely and reliably induce spinal fusion.